Protein Arginine Methyl Transferase and Hemochorial Placentation

Abstract
Successful mammalian reproduction depends on establishment of trophoblast cell lineage, which assures
anchorage of the embryo to the mother, establishes a vascular connection to transport nutrients and gases and
secretes hormones that are required for the progression of pregnancy. However, we have a poor understanding of
epigenetic mechanisms that regulate the biology of trophoblast cells and placentation in post-implantation
embryos. Our preliminary studies establish that protein arginine methyltransferases 1 (PRMT1), is conserved in
trophoblast cells of developing mouse and human placentae. Our loss-of-function studies indicate a critical role
of PRMT1 in placentation after embryo implantation. The overarching goal of this proposal is to elucidate how
PRMT1 function regulates trophoblast development and placentation to establishment of pregnancy. Two
specific aims are proposed.
In Aim 1 we will using a conditional Prmt1 knockout mouse model we will test the hypothesis that, PTMT1
function in trophoblast cells optimizes placentation in post-implantation embryos..
In Aim 2, using human trophoblast stem cells and primary trophoblast cells of a developing mouse placenta, we
will test the hypothesis that PRMT1 establishes a conserved gene expression program in mouse and human
trophoblasts and PRMT1-mediated transcriptional program is a key molecular regulator of trophoblast cell biology during
human placentation.
Successful completion of this proposal will define PRMT1-regulated gene signatures in trophoblast cells
that are critical for establishment of pregnancy after implantation. Defining these gene signatures will be an
important step in identifying trophoblast-specific causes that lead to pathological pregnancies, such as early
pregnancy loss.

Public health relevance
Relevance to Public Health: Defect in placentation due to impaired trophoblast cell development and functions lead to pregnancies that are at risk for miscarriage, intrauterine growth retardation, and preeclampsia, a leading cause of maternal death and premature birth. Therefore, understanding the molecular mechanisms of development and function of trophoblast cell lineages is critical to gaining insights into important features of pregnancy loss and pregnancy associated disorders.